WEB PAGE

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. Primary support for the subproject and the subproject's principal investigator may have been provided by other sources, including other NIH sources. The Total Cost listed for the subproject likely represents the estimated amount of Center infrastructure utilized by the subproject, not direct funding provided by the NCRR grant to the subproject or subproject staff. The web site for the Research Resource is intended to describe the core research and development projects, provide access to information about the symposium and other trainining opportunities, and to provide access to software. For example, TCASIM and TCACALC can be downloaded from the webpage. For further information, please go to: http://www.utsouthwestern.edu/utsw/home/research/AIRC/index.html The web page provides a roster of faculty and staff, records of the symposia, description of equipment, meeting schedules, an explanation of collaborative opportunities, magnet schedules, and all materials necessary for studies with human subjects including a Procedures Guide, Research Application, MR Screening Form, and a Modification Application. A description of the animal facility and contact information is also provided.